Administrative Core

ABSTRACT
An Administrative Core will coordinate and facilitate all activities within the U19 HIPC Group. This
Core will be responsible for the overall organization, management, decision-making, and
communication in the project, as well as utilization of institutional resources. The Administrative Core
will provide oversight and consultation to each of the Research Projects and Scientific Cores to
ensure that scientific objectives are met and that there is optimal utilization of resources. Specifically,
the Administrative Core will: monitor and assist each group so that their goals are achieved and
emergent problems are expeditiously addressed; provide fiscal management and ensure cost-
effective utilization of U19 resources; promote the communication and dissemination of research and
technology; and organize the presentation and publication of data. This Core will also ensure data
sharing, protection of intellectual property, and long-term data storage in coordination with the
ImmPort Data Repository. The Core Director chairs progress meetings and advisory committees to
oversee progress and promote the success of the Research Projects and Cores.